An inducible dual up/down gene regulation CRISPR system to study neuronal activity and regeneration

ABSTRACT
The dynamic processes of axon regeneration and neuronal repair are governed by an intricate network of genetic
pathways that involve multiple genes to be activated and repressed, but a full comprehension of how these genes
interact remains elusive. While many individual genes that influence regeneration have been identi=ed, we do not yet
have an approach for simultaneously and inducibly activating and repressing gene expression in neurons, especially
in the context of dynamic process of neuronal regeneration during injury. An additional challenge is obtaining suf=cient
temporal control over when each gene is activated or repression due to the dynamic nature of these processes.
To address these unmet needs, we propose the development of a novel synthetic biology platform consisting of an
inducible and multiplexed dual gene modulation system that is capable of simultaneous and sequential gene activation
and suppression to characterize genetic interactions and therefore enhance neuronal regeneration following injury.
Our system will take place in human induced pluripotent stem cell (iPSC) lines that can be effectively induced into
neurons (iNs). By targeting speci=c groups of genes known to regulate axon regeneration for activation and repression
at the same time, we will characterize how the system can be used to reveal multi-gene contributions in promoting
neuron regeneration. Our approach leverages recent advances in CRISPR-based multiplexed tools, namely
hyperdCas12a and Cas13d, both capable of processing own highly compact guide RNA arrays to target multiple loci
with high precision, while Cas12a targets DNA for activation and Cas13d targets mRNA for repression. We will engineer
a system containing both hyperdCas12a and Cas13 capable of inducible and multiplexed simultaneous gene activation
and repression with temporal control. In Aim 1, we will develop an inducible and multiplexed system in neurons that
are differentiated from iPSCs and characterize our system’s effectiveness in enhancing neuron regeneration beyond
single gene perturbations. In Aim 2, we will utilize multiplexing technology to de=ne an epistatic network of interacting
genes (50 genes) across different stress conditions in neurons. Subsequent neuron injury-based functional validations
of these computation results will determine the roles of these interactions in neural protection and regeneration. Our
proposed project will establish a novel and impactful platform for inducible and dual multiplexed gene regulation in
neurons. Our system offers an effective technology to target multiple genes dictating neural regeneration potential,
thus providing a means of achieving axon regeneration beyond what has been reported. Our work addresses unmet
needs in synthetic neuroscience and provide a unique strategy for studying neuron regeneration. Ultimately, our work
will help the broader scienti=c community by 1) providing a broadly useful tool to activate and repress multiple genes
in an ‘all-in-one’ system; and 2) delineate gene interactions and pathways in neurons to influence neural regeneration.

Public health relevance
PROJECT NARRATIVE Individual regeneration-associated genes have been uncovered for roles in controlling regeneration, but it is not yet established how these genes interact to dictate axon repair and regeneration. This project develops a novel CRISPR-based technology that is capable of simultaneously activating and repressing multiple genes with tight temporal control in neurons. We will demonstrate the utility of the technology for uncovering genetic interactions that synergistically promote or inhibit neuronal survival, repair, and regrowth after nerve injury stress signals.